Podocyte diseases: Pathogenesis and novel therapies

There has been no new patient enrollment to the retinoid study between 2008-2009. We are currently evaluating a patient for participation in the protocol. Thus far, there has been a total of four patients who have participated in the protocol. One of the four patients prematurely exited protocol to receive standard therapy because of unrelenting symptoms of nephrotic syndrome. The three patients who completed the protocol have not responded to the retinoid therapy. No significant adverse events have occurred in the protocol thus far.